Impact of dysbiosis on the development of age-related inflammation

PROJECT SUMMARY
The “pillars of aging” hypothesis entails that chronic unresolved inflammation, coupled with metabolic
dysfunction and macromolecular damage are among the key mechanisms that impairs cellular renewal and
regenerative processes that contribute to aging and chronic diseases. Inflammation is a protective mechanism
that has evolved to protect against pathogens and tissue injury that enables a host to survive life-threatening
challenges by restoration of homeostasis. How then does a protective response like inflammation become
chronic, drive aging and serve as a trigger of chronic disease? In absence of overt infections in aging,
alterations in the gut microbiota (dysbiosis) or potential translocation of microbiota derived PAMPs to liver,
mesenteric and omental adipose tissue could contribute to the mechanism of age-related inflammation. In line
with this possibility, recent studies have demonstrated profound changes in the microbiome associated with
aging and suggest that the microbiome may play a causal role in certain aspects of inflammaging. We recently
discovered that aging is associated with formation of tertiary lymphoid structures, called Fat-associated
lymphoid clusters (FALCs), in the visceral adipose tissue. The FALCs, unlike lymph nodes are disorganized
non-encapsulated non-classical lymphoid tissues associated to adipocytes contain T cells, B cell and
macrophages. Moreover, we found that B cells expand with age in the FALCs and display a unique
transcriptional profile reminiscent of antigen-experienced B cells. Based on our original findings, the central
hypothesis of this application is that translocation of gut microbes to visceral adipose tissue results in FALC
formation and age-related inflammation leading to metabolic dysfunction. We will test the mechanism of how
preventing the translocation of microbiota protects against FALC formation and inflammaging.

Public health relevance
PROJECT NARRATIVE The trillions of microbes inhabit the human intestine (our microbiome) also change dramatically during the aging process. This application will study how gut microbiota changes with aging can cause inflammation leading to decline of health.